South Dakota Biomedical Research Infrastructure Network

South Dakota Biomedical Research Infrastructure Network (SD BRIN), hosted by the Sanford School of
Medicine of the University of South Dakota (USD) in Vermillion, SD, is the SD component of IDeA
Networks of Biomedical Research Excellence (INBRE) funded by the NIH/NIGMS Institutional
Development Award (IDeA) program since 2002. This proposal has evolved from insights gained and
enhancements made during the previous phase of INBRE (2015-2020) especially related to the
successful implementation of the Developmental Research Project Program for advancing the research
initiatives of participating faculty members from our partners at predominantly undergraduate
institutions. The specific aims of the SD BRIN program have not changed from its beginning. SD BRIN
Aim 1 addresses the needs of biomedical researchers at USD (the lead research intensive institution) and
provides resources and support to other researchers throughout the state. SD BRIN Aim 2 addresses the
needs of science faculty and undergraduate researchers at the partner predominantly undergraduate
institutions and tribal colleges. Therefore, the aims of this phase of INBRE in South Dakota are to:
1) Continue to develop the research capacity of South Dakota in the area of cell biology and the control
of cell growth with special emphasis on proteomics and genomics by: a) enhancing the research capacity
of investigators in proteomics, b) maintaining proteomics, bioinformatics, and nucleic acid sequencing
and genotyping core facilities (with professional staff) accessible to investigators throughout SD (and
other IDeA states), c) offering opportunities for graduate training in proteomics, nucleic acid sequencing,
and bioinformatics, and d) supporting access to online library scientific databases to all faculty and
students from all SD BRIN participating institutions.
2) Develop human resources for undergraduate and graduate programs in the biomedical sciences and
bioinformatics by helping to instill a culture of research and provide a pipeline for students interested in
biomedical research at South Dakota’s predominantly undergraduate institutions and tribal colleges by:
a) providing research support and mentoring for faculty from participating institutions, b) providing
opportunities for, and understanding of, cutting-edge scientific research for students at participating
institutions, c) introducing undergraduates to graduate programs and future careers in biomedical
sciences and bioinformatics, and d) enhancing science education and research capabilities at tribal
colleges, providing opportunities for further education and careers in science and research.

Public health relevance
PROJECT NARRATIVE SD BRIN has supported a robust network of faculty researchers throughout South Dakota in developing and maintaining new areas of biomedical research by providing expert resources in core facilities available to all researchers. In addition, SD BRIN has maintained a strong undergraduate research fellows program at predominantly undergraduate institutions (PUI) with growing research cultures to develop future biomedical researchers and to assist faculty mentors with their cutting-edge research efforts. The faculty fellows program has allowed PUI faculty to concentrate on their research efforts and use this support to increase publications and application to external funding agencies.